Recruitment Core RC1

Project Summary/Abstract Recruitment and Community Engagement Core (RC1)
The UConn Recruitment and Community Engagement Core (RC1), led by Dr. Julie Robison, will implement
Precision Gerontology through targeted recruitment and retention methods and establish customized procedures
for planning and managing recruitment activities for multiple investigations. Since 1996, the UConn Center on
Aging Recruitment and Outreach Core (COA Core) has provided recruitment services for >60 clinical trials
(>5,000 subjects enrolled in studies) involving older adults, supported by funding for recruitment allocated within
each parent grant. Currently, the Research Volunteer Registry includes >10,000 names of potential participants.
COA Core has extensive experience implementing a range of recruitment methods including media
planning/placement, developing individualized patient referral methods with medical provider groups, utilizing
medical records diagnosis codes, utilizing claim codes with collaborating insurance providers, and participating
and partnering in community engagement activities. COA Core also provides guidance and resources to
investigators for protocol development, regulatory compliance, and recruitment planning and implementation. In
partnership with the UConn Health Disparities Institute (HDI) led by Dr. Wizdom Powell (RC1 co-leader), we will
enhance COA Core's expertise and advance the science of community-based recruitment and retention of
diverse older adults, a potent source of heterogeneity for which greater precision is needed when targeting
interventions to improve function — the goal of Precision Gerontology.
RC1 activities will focus on building capacity through community-based participatory research (CBPR) involving
collaborative, equitable partnerships; encouraging involvement of community assets; connecting, supporting,
and serving communities; engaging all stakeholders; and effectively disseminating findings. RC1 will support
Pepper scholars, developmental projects, pilot and exploratory studies, and external projects consistent with the
OAIC mission. RC1 will enhance research participation opportunities for Black, Indigenous and People of Color
(BIPoC) populations, highlighting equity, inclusion, and diversity. We propose to formalize new and strengthen
existing partnerships in community and individual settings by conducting educational, action-oriented meaningful
practice and inviting participation in programs and studies.
Finally, we will make our recruitment services (including protocol development and regulatory guidance)
accessible to investigators who have not yet received funding and/or collaborate with organizations who may
have little or no experience but have interest in conducting aging research.

Public health relevance
PROJECT NARRATIVE Recruitment and Community Engagement Core (RC1) RC1 will facilitate precision recruitment and retention and establish customized procedures for planning and managing recruitment activities and services for OAIC investigators focused on Precision Gerontology. RC1 will enhance community partnerships to engage diverse older adults in research, will educate older adults and the research community about including older adults in research, and provide human subjects ethical and regulatory support to OAIC investigators.